Roles of novel cationic lipids in bacterial pathogenesis

Abstract
Lipids are major components of bacterial membranes and play vital roles in bacterial survival, host-pathogen
interactions and pathogenesis. An important mechanism used by bacteria to interact with hosts and cope with
antimicrobial stresses is the modulation of surface charge via alteration of membrane lipid composition. However,
membrane lipids remain uncharacterized for many significant bacterial pathogens, and our understanding of how
the bacterial cell surface contributes to pathogenesis is still very limited. We aim to address these important
knowledge gaps in our research on Gram-positive pathogens. We recently discovered novel, highly positively
charged glycolipids in a range of Gram-positive pathogens, including the neonatal meningitis pathogen
Streptococcus agalactiae (Group B Streptococcus; GBS). The overarching hypothesis of the project is that
cationic glycolipids impact Gram-positive bacterial cell surface biochemical properties and play crucial roles in
pathogenesis. Using GBS as a model organism, in Aim 1 we propose to investigate mechanisms for cationic
glycolipid-dependent blood-brain barrier disruption by GBS. We will examine key mechanisms involved in barrier
disruption, including loss of tight junctions, direct bacterial invasion and transcytosis, and inflammatory damage.
We will also characterize the role of GBS membrane vesicles during the pathogenesis of meningitis. In Aim 2,
we will investigate regulatory interactions between cationic glycolipids and lipoteichoic acid (LTA) biosynthesis.
Our genetic and lipidomic analysis show that these pathways have an inverse relationship because they utilize
the same substrates. This is a novel mechanism for regulating the cell surface structure-function of a Gram-
positive pathogen, and has relevance beyond GBS, as we have also identified novel cationic glycolipids in
multiple pathogenic enterococci. We will investigate this proposed mechanism further and quantify how this co-
regulation impacts the structure and level of GBS LTA using a combination of chemical, biochemical and genetic
approaches. In Aim 3, we will investigate the molecular mechanism for cationic glycolipid synthesis. The enzyme
that synthesizes novel cationic glycolipids is the Multiple Peptide Resistance Factor (MprF), a broadly distributed
virulence factor in bacteria. The molecular mechanism for lipid substrate selection by MprF enzymes is unknown.
Using molecular evolution, global statistical models, and machine learning approaches that analyze the entire
MprF family, we propose a rigorous dissection of MprF lipid substrate specificity in GBS, which will inform studies
of MprF structure-function in GBS and other pathogenic bacteria, and guide the discovery of other pathogenic
species producing cationic glycolipids. Overall, this project will elucidate the biosynthesis, distribution and
physiological functions of the novel cationic lipids in GBS and other Gram-positive bacteria and uncover their
roles in bacterial pathogenesis.

Public health relevance
Project Narrative Lipids are major components of bacterial membranes and help bacteria cause infectious diseases. Yet, membrane lipids remain uncharacterized for many significant bacterial pathogens. We investigate the roles of newly discovered, highly positively charged lipids in bacterial pathogenesis.